Computational and Statistical Methods for Genetic Association Studies of Disease Course Over Time

PROJECT SUMMARY ABSTRACT
Genome-wide association studies (GWAS) have been remarkably successful at mapping genomic loci for
complex human diseases. However, most studies use case-control designs based on disease occurrence at a
specific time point, such as diagnosis. overlooking genetic factors that influence the course of disease over
time, including initiation, onset, progression, severity, and therapeutic response. Time-to-event (TTE)
phenotypes capture both the occurrence and timing of disease activity. GWAS of TTE phenotypes can identify
genetic variants associated with disease onset and progression, providing insights for early prevention and
therapies aimed at halting disease progression. Large biobanks like UK Biobank, All of Us, and FinnGen,
which combine longitudinal electronic health records (EHR) with genomic data, offer unprecedented
opportunities to study genetics of TTE phenotypes. However, limitations remain in current computational and
statistical tools, especially for rare variants and admixed populations. Additionally, biobank heterogeneity—
differences in sampling strategies, follow-up times, and baseline hazards—poses challenges for meta-analysis
of GWAS on TTE phenotypes.
This project aims to overcome these barriers by developing innovative computational tools and statistical
methods for GWAS of TTE phenotypes in large biobanks and cohorts. Aim 1 focuses on creating scalable
methods for rare variant association tests on TTE endpoints, accounting for sample relatedness, population
substructure, and high censoring. Aim 2 develops novel approaches to include admixed individuals in GWAS
of disease onset and progression over time, enhancing inclusivity and reducing disparities in genetic discovery.
Aim 3 improves GWAS and meta-analysis methodologies for TTE endpoints by addressing biases like left
censoring, sampling bias, and collider bias, enabling robust integration of data across biobanks. The proposed
methods will be evaluated through extensive simulation studies and applied to multiple biobanks.
Successful completion of this project will provide new critical tools to advance our understanding of the
genetic basis of complex diseases, reduce health disparities, and fully harness the potential of biobank
resources for uncovering genetic factors influencing disease onset, progression, and treatment response.
These tools and results will be made available as open-source software and public datasets to ensure broad
accessibility to the research community. Additionally, we will continue to develop, distribute, and support open-
source software packages for the proposed methods.

Public health relevance
PROJECT NARRATIVE Complex diseases such as diabetes, cancer, and Alzheimer’s disease develop and progress through various stages over time. The proposed research address key limitations in current analytical approaches by developing advanced computational and statistical methods for rare variant analysis, incorporating admixed populations, and improving GWAS and meta-analysis methods to improve integration of biobanks. These advancements will help uncover genetic insights into disease onset and progression, ultimately driving improvements in prevention and treatment strategies.